MEASUREMENT OF BRAIN SPECIFIC PROTEINS AND RELATION TO SCHIZOPHRENIA TREATMENT

The overall goal of this project is to develop techniques to reliably identify brain specific proteins in cerebral spinal fluid of schizophrenic patients.